The mechanism of autolysin regulation in Vibrio cholerae

Project Summary
Most bacteria maintain a cell wall, an essential, mesh-like structure mainly comprising the polysaccharide
peptidoglycan (PG). Some of our most powerful antibiotics, the beta lactams (penicillins, carbapenems and
cephalosporins) target enzymes required for cell wall synthesis and derive their efficacy from their ability to not
only inhibit cell wall biogenesis, but also to actively cause its disruption. Cell wall disruption after exposure to
beta lactams is mediated by “autolysins”, a group of enzymes (amidases, lytic transglycosylases and
endopeptidase) with the capacity to cut a variety of chemical bonds within the PG mesh. Under normal growth
conditions, autolysins engage in important cell wall remodeling functions, such as PG mesh expansion during
cell elongation; how these functions are regulated to ensure proper PG maintenance is poorly understood. We
have shown that in the diarrheal pathogen Vibrio cholerae, the endopeptidases (EPs) ShyA and ShyC are
required for cell elongation during normal growth (the physiological functions of another paralogue, ShyB, are
unknown), but are also key factors mediating cell wall breakdown after exposure to beta lactam antibiotics.
How ShyA and ShyC are regulated to ensure proper cell wall maintenance in the absence of antibiotics is
unknown. Here, we propose experiments to build a thorough understanding of mechanisms of endopeptidase
regulation in V. cholerae on multiple levels. Since M23 EPs are well-conserved throughout Bacteria, our
experiments will likely yield insights with broad relevance to other pathogens. In Aim 1, we will dissect the
functional relationship between PG synthesis and degradation processes. We will also test the hypothesis that
ShyA and ShyC's direct interaction with cell wall synthesis complexes regulates their activity. In Aim 2 we will
precisely map structure-function relationships in EPs and discover additional regulators of their activity. In Aim
3 we will determine the mechanism of EP regulation by metal homeostasis. Taken together, these experiments
will provide us with an extensive framework of how an important human pathogen maintains the balance
between cell wall synthesis and remodeling, with the goal of discovering new potential targets for antibiotics
that modulate autolysin activity.

Public health relevance
Due to the alarming rise in antibiotic resistance development, we are in urgent need of new antibacterial therapies. Some of our most powerful current antibiotics (penicillins) are effective against bacteria because they cause unbalanced activity of “autolysins”, self-produced enzymes that kill cells by degrading the cell wall. Experiments proposed here will allow us to understand this degradation process better, paving the way for new strategies to exploit bacterial self- destruction through the development of novel antibiotics that target autolysins.